Discovery of novel openers of the understudied human drug target Kir6.1

Project Summary
Drug overdoses now kill more Americans per year than vehicle crash and gun deaths combined. Overdose
is a common outcome of opioid use disorder (OUD), which itself has been suspected to evolve from routine
prescription treatment of pain with opioid medications. This public health crisis has created a need for the
discovery of non-opioid medications to treat pain without eliciting rewarding effects that lead to addiction. New
molecular targets for pain therapies offer the best route towards elusive non-opioid medications to treat certain
kinds of pain, a fact that is recognized by the present FOA, for which this project is proposed. The ATP-
sensitive inward rectifier potassium channel 8 (Kir6.1/KCNJ8) has been linked to the control of postoperative
and cancer pain, but little else is known about this ion channel in the context of pain. Specifically, Kir6.1
openers/agonists may be novel analgesics, but drug-like, selective openers/agonists of any KATP family
channel have never been identified. Kir6.1 is also considered an understudied protein in terms of its validation
as a druggable target generally and is on the list of qualified drug targets for this FOA. We recently investigated
the regulation by palmitoylation of Kir6 channels. Our studies identified a druggable site utilized by the
palmitoylation mechanism, which provides an avenue to discover drug-like, small molecule opener/agonists
of these channels. We proved the principle that we could find selective openers of Kir6.2 by targeting this site
using in silico/virtual library screening (VLS) coupled with electrophysiological testing in engineered cell lines.
Here, we propose to use the same approach to screen for selective, drug-like openers of Kir6.1 and establish
preliminary structure-activity relationships (SAR) between channel opening and specific chemical
determinants in the ligands. Specifically, we will build highly accurate homology models of alternative
conformations of the Kir6.1/SUR2B complex and use ultra-large VLS to find the maximum number of diverse
chemical entities that fit with the target pocket in its agonist, antagonist and unknown conformations (Aim 1).
These conformations will be refined based on the observed activity of hit ligands. We will also develop three
orthogonal assays to test hit compound identified by VLS: a) a thallium flux cellular primary screening assay,
b) patch clamping of Kir6.1 and c) an LPS-stimulated, human astrocyte MCP-1/p-JNK elevation phenotypic
assay (Aim 2). Finally, SAR will be derived for each of the three assays, and a meta-SAR across the three,
which can serve as an advanced starting point for future drug discovery projects, will be inferred using
cheminformatics methods (Deliverable). A specific 3D structural agonist site on KATP channels has not
previously been identified, so this proposal is highly innovative.

Public health relevance
Project Narrative In service of the NIH’s HEAL initiative and in response to the opioid use disorder public health emergency, we will investigate the ATP-sensitive inward rectifier potassium channel 8 (Kir6.1/KCNJ8) as a novel, non- opioid, drug target to treat pain. In this exploratory project, the first steps in this direction will be taken by leveraging our success at identifying selective agonists of ATP-sensitive inward rectifier potassium channels to discover chemical entities that open the ATP-sensitive inward rectifier potassium channel 8. The deliverable of this project will be the data package of compounds, screening assays and structure-activity relationships necessary to determine if drugs targeting the ATP-sensitive inward rectifier potassium channel 8 can be developed as novel, non-opioid analgesics.